Supporting the Advancement of FDA's Integrated Food Safety System (IFSS) Training Delivery and Development

RFA-FD-25-016 – Project Summary/Abstract
The International Food Protection Training Institute (IFPTI) proposes to support the
advancement of FDA’s Integrated Food Safety System (IFSS) Training Delivery and
Development. Given its longstanding history of collaboration with FDA (through three
consecutive Cooperative Agreements) and its leadership role in designing and developing
the Human and Animal Food (HAF) National Curriculum Standard (NCS), IFPTI is
uniquely positioned to carry out the objectives of this proposed project.
The proposed project has three primary aims, all of which comprise a series of sub-aims
addressed in the Research Strategy. A further breakdown of all of the major activities and
Year 1 action items associated with all sub-aims can be seen in the IFPTI Project Activity
Chart appearing at the end of the Research Strategy and included as an attachment
(Appendix) to the Workspace.
Aim #1 focuses on Course Planning and will involve a series of activities designed to
enhance the overall course planning processes. Activities will include collaborating with
OTED on process improvement strategies, identifying and recruiting appropriate Subject
Matter Experts to serve as potential course instructors, delivering the Instructor Skills
Training (IST) course (CC100W), evaluating instructor performance, and maintaining a
comprehensive database of instructor-related records.
Aim #2 focuses on Course Design and Development and will primarily involve
collaborating with OTED on a variety of activities, including course development planning
meetings, course development oversight, developing and implementing course
enhancements, reviewing and piloting classroom (in-person and virtual) course content,
reviewing and piloting web-based course content, and researching new technologies and
modalities for learning.
Aim #3 focuses on Evaluation and will involve activities that leverage the recently
completed HAF NCS, the career-spanning competency standard for Human and Animal
Food Regulatory Professionals. Leveraging the NCS will involve collaborating with OTED
on the creation of a comprehensive FDA training resource catalog in alignment with the
NCS, utilizing NCS blueprints to either revise/update FDA training in alignment with the
NCS, or develop new FDA training in alignment with the NCS. Finally, IFPTI proposes to
develop a new NCS but for a non-food area regulated by FDA e.g., Medical Products.

Public health relevance
RFA-FD-25-016 – Project Narrative The International Food Protection Training Institute (IFPTI) proposes to support the advancement of FDA’s Integrated Food Safety System (IFSS) Training Delivery and Development through three primary Aims, all in close collaboration with OTED. Aim #1 focuses on activities designed to enhance the overall course planning process; Aim #2 comprises activities related to course design and development; and Aim #3 involves evaluation efforts and leveraging the recently completed National Curriculum Standard (NCS). Given its longstanding history of collaboration with FDA OTED (through three consecutive Cooperative Agreements), IFPTI is uniquely positioned to carry out the objectives of the proposed project.